An Observational Cross-Sectional Study of Virtual Reality Mobility Assessment of Functional Vision in Retinal Disease

The Observational Cross-Sectional Study of Virtual Reality Mobility Assessment of Functional Vision in Retinal Disease study was activated on July 24, 2023 and approved to enroll participants at the National Eye Institute, National Institutes of Health. All required documents were collected by the coordinating center. Participant
enrollment and data collection has begun. The first participant was enrolled August 25th, 2023. Activation of the University of Sydney site is anticipated for August 2023